Reinforcement mechanisms for auditory perceptual learning

PROJECT SUMMARY/ABSTRACT
It is commonly accepted that, when it comes to learning motor skills, such as dancing or sewing, “practice makes
perfect.” Less appreciated, however, is that our senses also benefit from practice. With training, we can improve
our ability to see, hear, smell, and taste – a process termed perceptual learning (PL). In the auditory system, PL
underlies key elements of human social communication, such as speech phoneme discrimination and musicality.
In the brain, PL is associated with changes in stimulus representations in sensory cortical regions. However,
passive stimulus exposure on its own is not sufficient to induce sensory cortical plasticity or PL, and extensive
training is required. Strikingly, if passively presented stimuli are paired with electrical stimulation of the ventral
tegmental area (VTA), visual cortical plasticity and improvements in visual perception can occur, suggesting that
VTA dopaminergic (DA) signaling may play a critical role in PL, at least in the visual system. The causal role of
VTA in auditory PL is entirely unexplored. In associative learning, VTA DA neurons encode prediction errors:
early in training, reinforcement, but not the preceding stimulus, drives strong neuronal firing. With training, VTA
DA neuronal firing gradually shifts from the now-expected reinforcement towards the preceding stimulus.
However, PL differs from associative learning, in that training for PL typically employs progressively weaker
renditions of a previously learned stimulus and ultimately results in improved detection. I hypothesize that to
improve detection of weak signals, the brain engages the same prediction error mechanisms that support
associative learning. I propose that reinforcement cues preceded by weak sounds are encoded as prediction
errors and drive VTA DA neurons to fire, thereby generating the improvements in cortical neural sensitivity that
give rise to PL. To test if VTA DA neurons signal prediction errors during PL, this proposal will employ fiber
photometry and high channel-count electrophysiology to monitor neurons in the VTA as freely moving Mongolian
gerbils train on an auditory PL task. Then, VTA DA neurons will be targeted with optogenetic manipulations during
behavior to evaluate if gain or loss of function affects PL at the behavioral and auditory cortical levels. This
proposal offers the first direct test of whether VTA’s role extends to auditory perceptual learning. My goal is to
establish an independent career focused on how reinforcement-dependent neuromodulation results in sustained
adaptive changes in auditory circuits. In the long-term, my research could inform the development of strategies
to enhance everyday perceptual skills or to improve sensory dysfunction in the hard-of-hearing population.

Public health relevance
PROJECT NARRATIVE The role of reinforcement brain circuits underlying auditory perceptual learning is entirely unexplored at the behavioral and cellular level. This proposal will address these gaps by monitoring and manipulating the midbrain’s reinforcement processing area as freely moving Mongolian gerbils train on an auditory perceptual learning task. In the long term, this proposal’s findings could help guide the development of strategies to enhance everyday perceptual skills and the design of interventions to improve auditory function in hard-of-hearing populations.